Pain and synovial pathotypes in AMP AIM

Clinical pain phenotypes and mechanisms in inﬂammatory arthri3s are poorly understood. The
Accelera3ng Medicines Partnership Autoimmune and Immune-Mediated Disease (AMP-AIM) Program
addresses common themes across autoimmune and inﬂammatory-mediated diseases, and understanding
the complexity and impact of pain and the dissocia3on between pa3ent and physician perceived disease
burden, not necessarily related to untreated inﬂamma3on, is a major unmet need. Pain phenotypes such
as nocicep3ve (3ssue injury), nociplas3c (central sensi3za3on), and neuropathic pain and their
contribu3on to therapeu3c non-response cons3tutes a cri3cal knowledge gap. Pain is a core domain
aﬀec3ng quality of life from the perspec3ve of pa3ents with Rheumatoid Arthri3s (RA), Psoria3c Spectrum
Disorder (PSD), Sjögren’s disease, and Systemic Lupus Erythematosus (SLE). This supplement will support
adding comprehensive and uniform measurements of pain phenotyping to exis3ng data collec3on in RA
and PSD pa3ents with prominent synovial pathology and both peripheral and central pain sensi3za3on, in
parallel with the harmonized eﬀorts in SLE and SJD. Speciﬁcally, we will 1. Iden3fy pain phenotypes
associated with peripheral and central mechanisms of pain and in treatment non-responders, using both
pa3ent reported outcomes (PROMIS 29, 2016 Fibromyalgia Survey) and algometer measured Quan3ta3ve
Sensory Tes3ng (QST) of joint-speciﬁc hyperalgesia with a trapezius reference to assess central pain
sensi3za3on, 2. Iden3fy novel mediators of pain in the RA and PsA synovium building on work that
iden3ﬁed a gene signature correla3ng with pain, where axon sprou3ng and neuron projec3on organiza3on
were among the most signiﬁcantly enriched pathways. Using synovial biopsies obtained in AMP-AIM, we
will apply 3-dimensional staining and volume imaging to understand the interac3ons between synovial
sensory nerves and synovial cell types. These studies will provide novel insights into pain sensi3za3on,
non-response, and new treatment approaches.

Public health relevance
Clinical pain phenotypes and mechanisms in inﬂammatory arthri3s are poorly understood. The Accelera3ng Medicines Partnership Autoimmune and Immune-Mediated Disease (AMP-AIM) Program addresses common themes across autoimmune diseases. This supplement to AMP-AIM focuses on understanding the complexity and impact of pain in pa3ents with Rheumatoid Arthri3s and Psoria3c Arthri3s, the most common causes of inﬂammatory arthri3s.